The Role of MicroRNAs in Normal and Diseased Corneal Epithelial Homeostasis

Corneal diseases and injuries leading to visual impairment have significant impact on the quality of life of
patients and constitute a major problem for health care system. Corneal diseases are often manifested through
limbal epithelial stem cell (LESC) dysfunction and loss, leading to corneal opacity, visual impairment, and
blindness. LESC located in the limbal niche are the source of constant corneal epithelial renewal and are
required to maintain corneal epithelial homeostasis by adapting properly to internal and external stimuli.
However, persistent exposure to pathological stress disrupts the adaptive mechanisms of LESC, leading to
serious corneal problems such as altered wound healing, limbal stem cell deficiency (LSCD) and diabetic
keratopathy. Therefore, understanding the precise spatial and temporal regulatory pathways and how each
LESC/limbal epithelial cells (LECs) responds to various stimuli at the single-cell level governing corneal
epithelial regeneration could be key to elucidating the pathogenesis of various corneal diseases and ultimately
developing new and effective treatment strategies. Previously, we have shown the important regulatory role of
miR-146a in corneal epithelial homeostasis and wound healing via its different targeted pathways such as
EGFR, Notch and NF-κB signaling. However, due to the heterogeneity of limbal basal cells and their proximity
to limbal stromal cells, it remains to be determined how miRNAs (miRs) regulate maintenance, differentiation,
and the active stage of limbal progenitor cells in various corneal cell populations in wounded and unwounded
normal and diseased corneas. Recently several studies have shown the heterogeneity and complexity of limbal
niche in relation to regeneration and wound healing and identified new putative LESC markers using newly
emerged empowering scRNA-seq technology. We propose to investigate the regulatory role and contribution of
each miR-146 main targets (EGFR, TRAF6, IRAK1, NUMB and NOTCH-2) in corneal epithelial regeneration in
wounded and unwounded states in normal and diabetic corneas using scRNA-seq, proteomics, loss and gain
of functional studies. We hypothesize that miR-146a contribute to the molecular regulation of cellular
heterogeneity in the limbal niche steady state. We predict that differential miR-146a expression in limbus vs.
central corneal epithelium impacts its regulation of limbal niche cells, LECs and limbal stromal cells, and
mediates corneal regeneration and wound healing in normal and diseased states. Our Specific Aims are:
Specific Aim 1: To identify and characterize downstream targets including EGFR, Notch and inflammatory
mediators of miR-146a in distinct populations of heterogeneous limbal stem cells that contribute to homeostatic
maintenance and regeneration in human normal unwounded and wounded cornea. Specific Aim 2: To reveal
the differential and converged regulatory role of EGFR, inflammatory, and Notch signaling by miR-146a in
corneal epithelial homeostasis and wound healing. Specific Aim 3: To investigate miR146a-based therapeutic
approach by modulating its targets in human diabetic organ-cultured corneas.

Public health relevance
PROJECT NARRATIVE Corneal diseases and injuries that are often manifested through limbal stem cell dysfunction and loss are the major cause of visual impairment and corneal blindness. Our previous studies and scRNA- seq preliminary data formed the premise for the present proposal to uncover the regulatory role and contribution of each miR-146a main targeted pathways such as EGFR, Notch and NF-κB signaling in corneal epithelial regeneration in wounded and unwounded states in normal and diabetic corneas. This research will significantly advance our understanding of miR-146a mechanisms of regulation in corneal epithelial homeostasis, wound healing, and disease-related alterations for future therapeutic approach.